Profiling of Midbrain Neuronal Vulnerability in Parkinson's Disease

Project Summary/Abstract
Parkinson’s disease (PD) is the second leading neurodegenerative disorder in the United States with patients
manifesting motor and psychiatric complications. As the global population ages, the prevalence of PD will
increase accompanied by emotional and economic burden. PD is characterized by the degeneration of
neuromelanin-containing dopaminergic (DA) neurons in the substantia nigra (SN). It remains poorly understood
how this degeneration occurs. The use of single-cell RNA sequencing has significantly advanced our
understanding of neurodegenerative disease–several studies in mouse midbrains identify the heterogeneity of
DA neurons; however, limited studies have been conducted in human samples. To fill this gap, we have
performed single-nucleus RNA sequencing (snRNAseq) and profiled the cells from healthy and PD human SN,
which identified a novel degenerating neuronal population in PD that is highly enriched with RIT2 but lacks
tyrosine hydroxylase (TH), a typical marker for DA neurons (RIT2+/TH-). It is not known whether non-DA neurons
in the SN are also vulnerable in PD. Immunostaining of aged healthy and PD human and murine SN samples
validated the distinct RIT2 populations (RIT2+/TH+, RIT2+/TH-). This proposal aims to characterize distinct RIT2
neuronal subpopulations in the SN to elucidate its cellular heterogeneity and to identify potential mechanisms
underlying the complexity of PD symptoms. The driving hypotheses are that subpopulations of RIT2
neurons in the SN are distinct from DA neurons with unique morphology, function, and circuits (AIM 1)
and that RIT2 neuronal subpopulations in the SN are vulnerable to PD-associated pathogenesis (AIM 2).
Aim 1 will characterize the novel RIT2-expressing neuronal subpopulations in mouse SN. Aim 2 will assess the
vulnerability of RIT2 neuronal subpopulations in both PD mouse models and human midbrain neurons. These
studies will elucidate whether non-DA neurons in the SN are degenerating in PD and they will characterize
distinct RIT2 subpopulations in the SN, providing mechanistic insights into the complexity of PD and identify
pathways warranting further exploration for therapeutic development. This proposal is highly innovative because
it will characterize a novel midbrain neuron type with vulnerability in PD that may lead to insights into resilience
mechanisms. This proposal will also generate several novel model systems in both mice and hiPSC, which will
be available to the research community. Completion of this proposal will provide rigorous multidisciplinary
training for the candidate in assessing cell circuit innervations, transcriptomics, cell viability, and functional testing
of neuronal subpopulations in transgenic mice and hiPSCs. This fellowship will enrich and accelerate the career
of a promising PhD student with demonstrated dedication to research in aging-related neurodegenerative
disorders and education. The training will be conducted in a highly multidisciplinary and collaborative
environment in the Department of Neuroscience at Icahn School of Medicine at Mount Sinai, a leading institution
with emphasis in translational and transformative discoveries.

Public health relevance
Project Narrative Studying the heterogeneity of midbrain neuronal subpopulations in the substantia nigra (SN) may point to mechanisms that explain the differential vulnerability of neuronal subpopulations in the context of Parkinson’s disease (PD). The proposed research aims will investigate a novel vulnerable midbrain neuron type using transgenic mouse reporter lines as well as human-derived midbrain neurons. This study will elucidate whether non-dopaminergic neurons in the SN are also vulnerable in PD as well as highlight novel mechanistic insights into the complexity of PD symptoms.